Developing research leaders at the intersection of malnutrition and tuberculosis in Tanzania

ABSTRACT/ SUMMARY
In non-pandemic periods, tuberculosis (TB) is the leading killer worldwide from a curable infectious disease.
Malnutrition related immunosuppression is the most important driver of conversion from latent Mycobacterium
tuberculosis infection to active TB disease. Yet TB disease itself worsens malnutrition, while the physical,
social and economic consequences of TB treatment all predispose to sequelae of persistent malnutrition. The
United Nations and World Health Organization’s End TB Strategy recommends scaling-up of research training
of scientists in TB endemic settings skilled in the End TB research goals. Given that researchers and
educators from the University of Virginia (UVA) and Tanzania are currently working in collaborative research in
multiple domains of malnutrition and TB, we performed a countrywide needs assessment to map the
competencies of successful research leaders identified in the Path to Research Leadership Report in Africa
2020. We then designed the current Global Infectious Diseases Research Training Program (GIDRTP- D43
TW012247, now grant year 2), to train 6 postdoctoral Tanzanian scientists in research leadership excellence at
the intersection of malnutrition and TB, and within the components of research team management,
communication, grant writing, professionalism and career trajectory. Tanzanian postdoctoral scientists receive
3 years of salary support, mentorship with UVA and Tanzanian faculty at strategic institutes, and lead a team
of staff scientists, Tanzanian Master’s students, and undergraduate students from UVA (2 per postdoctoral
scientist led team) utilizing the eGlobal program of virtual/online engagement.
While interest is high for undergraduates across varied schools at UVA for participation in the GIDRTP and
eGlobal program, the majority have prior global travel experience and do not identify as underrepresented in
health sciences. Furthermore, the current eGlobal program does not provide a summative travel experience to
Tanzania. This supplement will 1) recruit and retain 8 new undergraduate students that are underrepresented
in health sciences for a year’s longitudinal internship in global research engagement and a summative hands-
on research experience in Tanzania with their Tanzanian postdoctoral scientist-led team; 2) do so through
equitable compensation of stipend during the internship; 3) provide UVA faculty led training for undergraduates
in global health career tracks, methods of cross-cultural research collaboration, and pre/post travel counseling;
and 4) advance the research team leadership skills of the Tanzanian postdoctoral scientists following the
integration of undergraduates with diverse lived backgrounds. We expect this adaptation of the eGlobal
program for underrepresented minorities in global health sciences can be scaled to other training programs
and scientific foci.

Public health relevance
NARRATIVE In non-pandemic periods, tuberculosis (TB) is the leading killer from a curable infectious disease. Malnutrition, both undernutrition and poor nutrition leading to conditions such as diabetes mellitus, is the most important driver of TB disease globally. This Global Infectious Diseases Research Training Program (GIDRTP) strengthens existing educational and research linkages with the University of Virginia and the Kilimanjaro Christian Medical University College/ Kilimanjaro Clinical Research Institute in Tanzania to develop research leaders working in malnutrition and TB at the postdoctoral level. Tanzanian postdoctoral trainees lead research teams composed of Tanzanian Masters students and undergraduates from schools such as Data Science, Engineering and Arts and Sciences at University of Virginia through a virtual/online internship (eGlobal). This supplement will provide eight undergraduate students that are underrepresented in health sciences an equitably compensated longitudinal internship in global research engagement utilizing the eGlobal program, and summative travel to Tanzania with their postdoctoral scientist-led team. Contributions from undergraduates with diverse lived backgrounds will advance the research team leadership skills of the Tanzanian postdoctoral scientists, and lessons learned in adapting the eGlobal program will facilitate further scale up of this approach.